Commercialization of a rapid, automated Hi-C platform for sensitive genomic profiling of multiple cancer sample types

ABSTRACT
Cancer is projected to affect 20M people worldwide in 2023, with new cases increasing almost 30% in the next
two decades. Cancer is a complex disease caused by a vast range of genetic and epigenetic defects. Existing
technologies often fall short in comprehensively identifying the various genetic aberrations underlying different
cancer types. A significant number of cancers remain without detected actionable or causative variants,
revealing a critical gap in our understanding, and delaying or preventing the use of targeted treatments. To
address this gap, we have developed an innovative Hi-C workflow that we call VariLink™. VariLink overcomes
many of the limitations of current genomic technologies and substantially enhances the detection of cancer-
driving structural variants (SVs) in the genome. By leveraging the 3D structure of the genome to incorporate
long-range linkage information into the sequencing library, VariLink enables highly sensitive detection of large
SVs, while maintaining shotgun-like detection of smaller variants such as small nucleotide variants (SNVs) and
insertions/deletions (indels). VariLink also overcomes the drawbacks of other commercially available Hi-C
technologies with its 1) rapid workflow (<8 hours vs. 2-3 days); and 2) unbiased genome coverage, enabling
more accurate variant calling. By combining and exceeding the capabilities of existing methods, VariLink can
uncover a broader spectrum of genetic and epigenetic changes in a single assay from a single sample. In our
Phase I-equivalent work, we performed initial development of VariLink and demonstrated its performance
relative to existing Hi-C assays. We also showed feasibility in clinically relevant tissue types, including blood.
Importantly, we showed that VariLink detects SVs at much higher sensitivity than standard whole-genome
sequencing technologies. In our Phase II work, we aim to further validate the performance of VariLink across
multiple clinical sample types and compare it to standard molecular cytogenetic technologies. We also aim to
adapt VariLink for formalin-fixed, paraffin-embedded (FFPE) samples and develop high-throughput automation
and data analysis protocols. Successful completion of this project will demonstrate VariLink's performance in
comprehensive variant detection and its suitability for commercialization in the translational research and
clinical oncology space. By enabling more sensitive detection of genetic alterations in cancer patient samples,
VariLink could contribute to improved targeted therapies, drug discovery, and reduced cancer mortality. With a
focus on the expansive cancer diagnostics market, we anticipate VariLink's eventual adoption as a diagnostic
test, pushing cancer genomic characterization beyond the limitations of current assays.

Public health relevance
NARRATIVE Up to 25-50% of diagnosed cancers remain without an identifiable driver mutation due to limitations of current diagnostic technologies, reducing the applicability of targeted treatments. While current approaches based on next-generation sequencing technology can detect small mutations with >99% accuracy, detecting larger structural variants and alterations in overall DNA structure that contribute to tumorigenesis is more challenging. The goal of this SBIR is to optimize and validate a rapid, automatable proximity ligation-based assay for enhanced detection of structural alterations in multiple cancer types.